Planning grant for Take Off Pounds Sensibly (TOPS) for African American (AA) Cancer Survivors

1. Abstract
Our long-term goal is to decrease the weight-related breast cancer and cardiovascular disease mortality among
African American breast cancer survivors. In the R01 application, our overall objective is to determine the real-
world effectiveness of the materials developed during the R34 – Take off Pounds Sensibly (TOPS) for African
American Breast Cancer Survivors – on weight. Our central hypothesis is that TOPS for African American Breast
Cancer Survivors will help participants achieve significant weight loss. This hypothesis is based on the following:
1) our preliminary data show that TOPS can help women achieve and maintain significant weight loss; 2) the
materials from the Moving Forward and Lifestyle, Exercise and Nutrition (LEAN) studies, which we are adapting
to add to the TOPS program to create TOPS for African American Breast Cancer Survivors, have been shown
to help breast cancer survivors achieve significant weight loss; and 3) the additional materials will be approved
by African American breast cancer survivors who have already participated in the TOPS program. To plan to test
the central hypothesis, we will pursue the following specific aims in the R34: 1) Adapt materials from Moving
Forward and LEAN with the input of African American breast cancer survivors; 2) Conduct a pilot test of the new
materials and study processes where we a) recruit participants through the electronic health record; b) convert
from a peer-led to a dietitian-led intervention for the initiation phase; c) transition participants to TOPS chapters
in the community for the maintenance phase; and d) collect data in a virtual setting and in the community. The
proposed research is innovative because for the following reasons: 1) it combines efficacious weight
management programs developed at academic institutions with a low-cost community-based program with
national infrastructure; 2) it transitions participants to a maintenance phase in their communities where they can
receive ongoing support indefinitely; 3) it collects data via Bluetooth scales and at LabCorp sites in their
communities; and 4) to our knowledge, this is the first study to test a sustainable weight management intervention
for African American breast cancer survivors. The proposed research is significant because it will develop the
evidence base for a scalable weight loss intervention among African American breast cancer survivors – a
population with poor breast cancer and cardiovascular disease outcomes. The rationale for this project is that
the successful completion is expected to provide evidence that a community-based, weight loss program with a
national infrastructure can help African American breast cancer survivors manage their weight, which may
decrease their breast cancer recurrence and mortality; reduce CVD morbidity and mortality; and improve their
quality of life.

Public health relevance
2. PROJECT NARRATIVE The proposed research is relevant to public health because if a low-cost, community-based weight loss program with a national infrastructure is effective at weight loss among African American breast cancer survivors with excess weight, it has the potential to reduce of the health disparities of excess weight; breast cancer recurrence and mortality; and cardiovascular disease mortality among African American breast cancer survivors. The proposed research is relevant to the part of the NIH mission that pertains to enhancing health and reducing illness and disability.